Multipurpose Device for Female-initiated Nonsteroidal On-Demand Contraception

PROJECT SUMMARY/ABSTRACT
The challenge of the future is to develop innovative, female-initiated contraceptive technologies that are afford-
able, socially acceptable, and provide desired protection from unintended pregnancy without exposing women
to additional health risks associated with systemic distribution of contraceptive hormones. Our preliminary data
demonstrate discovery of drug-free, bioresponsive polymer compositions that dramatically increase in viscosity
upon exposure to semen, thereby effectively preventing pregnancy in vivo. In an expansion of this pioneering
SMART (= System Mute until Activation by a Remote Trigger) polymer concept, we propose a novel delivery
technology using an on-demand dual-compartment vaginal device that enables women to fortify the nat-
ural contraceptive barriers at the cervicovaginal junction without pharmacological action of drug mole-
cules. This high-risk/high-reward research strategy is fundamentally different from conventional nonsteroidal
contraceptive methods as it represents a drug-free bioengineering approach intended to reach the human testing
phase (i.e., IDE milestone for medical devices) much faster and at a lower cost than conventional development
programs focusing on pharmacologically active agents. For this study, it is hypothesized that development of a
multipurpose device enables women to accurately deposit a small dose of a fabric-like, polymeric SMART fiber
mats intravaginally and, simultaneously, administer supplemental fluid to accelerate reconstitution of a biore-
sponsive, acid-buffering, and mucoadhesive SMART gel phase that fortifies the natural contraceptive physical
and chemical barrier properties at the cervicovaginal junction. In Aim #1, we will design a dual-compartment
device for female-controlled intravaginal administration of contraceptive SMART fiber mats and fabricate proto-
type devices for in vitro testing of critical device performance characteristics. In Aim #2, we will conduct bench
testing of dual-compartment device prototypes in vitro to evaluate fiber insertion and SMART gel formation. In
Aim #3, we will solicit feedback from women on acceptability and end user desirability of different prototype
devices using focus group discussions to define human factors contributing to use-related safety and efficacy
risks of the multipurpose device designed for female-initiated vaginal delivery of contraceptive SMART fiber
mats. Finally, we will assess performance, safety, and efficacy of the optimized multipurpose device for vaginal
delivery of contraceptive SMART fiber mats in vivo using the sheep model (Specific Aim #4).

Public health relevance
PROJECT NARRATIVE Innovative, female-initiated contraceptive technologies are needed that are affordable, socially acceptable, and provide desired protection from unintended pregnancy without exposing women to additional health risks asso- ciated with systemic distribution of contraceptive hormones. This application seeks to develop a novel delivery technology using an on-demand dual-compartment vaginal device to provide women with a different choice in their personal decision of managing fertility throughout their reproductive lives. The proposed bioengineering approach is fundamentally different from conventional designs of non-hormonal, on-demand contraceptive tech- nologies as it enables women to fortify the natural contraceptive barriers at the cervicovaginal junction without pharmacological action of drug molecules.